The Effects of Early Psychosocial Deprivation on Cardiometabolic Risk in Early Adulthood

Project Summary/Abstract
The Bucharest Early Intervention Project (BEIP)—the only randomized controlled trial (RCT) comparing foster
care to institutional care for young children—was designed to address essential questions about human
development and when and how to intervene with children exposed to early severe psychosocial deprivation.
The BEIP has identified the effects of being raised in large institutions in life on psychopathology and brain
structure and function, yet, to date, understanding of the broader health consequences remain unknown. We
propose a new assessment of BEIP participants at age 22 years to provide data regarding cardiometabolic risk
factors and health behaviors to answer timely questions about the long-term impact of severe early neglect,
and the subsequent social experiences and biological risk factors capable of attenuating or amplifying later
health risk as these individuals enter adulthood, a key time period for cardiovascular risk. This proposal
leverages existing repeated assessments from when the participants were infants and toddlers still living in
institutions, after randomization to care as usual or foster care placement, and through age 16. We propose to
conduct physical health assessments of BEIP participants at age 22, via clinical examinations, laboratory tests,
and self-reported health behaviors. We will assess six outcome domains: 1) body size, fat, and fat distribution;
2) blood pressure; 3) serum-based metabolic risk markers; 4) inflammatory biomarkers, 5) telomere length,
and 6) self-reported health behaviors, including sleep, physical activity, alcohol and tobacco use, and diet. In
Aim 1, we will examine the long-term effects of early institutionalization and the foster care intervention on
cardiometabolic risk in young adulthood. In Aim 2, we will evaluate the moderating effects of stress reactivity in
adolescence and telomere attrition from mid-childhood to adulthood on the associations between early
institutionalization and foster care on cardiometabolic risks in young adulthood. In Aim 3, we will determine the
moderating effects of institutional rearing and foster care on the associations between stressful life events and
cardiometabolic risk. Our overarching hypothesis is that severe neglect in early life will negatively impact
cardiometabolic wellbeing in young adulthood and that subsequent social experiences and biological risk
factors can moderate this trajectory. Our proposal is innovative as the RCT design provides an unparalleled
opportunity to test how early psychosocial deprivation and later caregiving shape cardiometabolic risk in early
adulthood. Our results will provide the most comprehensive examination to date of the long-term impact of
early deprivation and foster care on cardiometabolic risks and related health behaviors. This proposal is
significant as it is expected to inform policies pertaining to millions of children exposed to institutional care
worldwide and clinical practices for children exposed to the most prevalent form of child maltreatment, neglect.

Public health relevance
Project Narrative In this proposal we build on a unique randomized controlled trial of foster care as an alternative for institutional care based in Bucharest, Romania. This valuable sample of children will be studied when participants are 22 years of age when we will examine the long-term consequences of early psychosocial deprivation and early intervention on cardiometabolic risk factors and health behaviors at the start of adulthood. This project will contribute significantly to our understanding of ways in which children exposed to early psychosocial deprivation are affected by their experiences and will directly inform policies and clinical practices.